Are all Protein Aggregates Toxic?

This application is in response to NOSI (NOT-GM-22-017) to acquire a Circular Dichroism
Spectropolarimeter as part of an administrative supplement. PI has an active eligible R15 grant
(1 R15GM148964-01) with enough remaining time to proceed with a supplement request.
Currently, Michigan Tech does not have a CD instrument. Having access to this instrument will
greatly enhance PI’s research ability to address specific aim 2 (Characterize physicochemical
properties of the diverse protein aggregates) of the funded grant (1 R15GM148964-01).
Circular Dichroism can track changes in the secondary structure of proteins undergoing
misfolding and aggregation. This technique – in combination with other biophysical and
biochemical methods such as chromatography, fluorescence, SEM, AFM, and TEM – will help
to better characterize the unique physicochemical properties of the protein aggregates and
correlate aggregates’ structure to its associated toxicity.

Public health relevance
This request for administrative supplement is to acquire a circular dichroism (CD) instrument that will help characterize protein aggregates’ secondary structure. In combination with other physicochemical methods, CD will help to better understand the relationship between protein aggregates’ structural diversity and their associated toxicity.